Development and functions of tissue resident memory T cells during EAE

Project Summary
Multiple sclerosis (MS) is an autoimmune disease of the central nervous system (CNS) characterized
by demyelination, axonal loss, and progressive disability. The disease can follow a relapsing remitting or a more
chronic course. Similarly, experimental autoimmune encephalomyelitis (EAE) models are characterized by CNS
inflammation and demyelination, and each recapitulate some aspects of MS. Although there is a wealth of
knowledge regarding the association of different circulating T helper (Th) subsets with multiple sclerosis (MS),
there is a paucity of information regarding the characteristics and functions of tissue resident memory T cells
(TRM) which have been recently identified in the central nervous system (CNS) and the cerebrospinal fluid
(CSF) of MS patients. To begin to address this gap, we have used a newly developed mouse strain to identify,
track, characterize and eliminate TRMs during the course of experimental autoimmune encephalomyelitis (EAE).
We propose that autoreactive CNS CD4+ TRM express a unique set of markers that distinguish them from other
circulating central memory T cells and play an important role in disease progression. Using our newly developed
tools, we will characterize the distribution, kinetic and characteristics of CD4+ TRM cells during EAE, establish
whether they recirculate and participate in disease progression and relapses during EAE. The completion of this
proposal will help us understand how memory T cells promote chronic autoimmunity and may lead to the
development of novel therapies for MS.

Public health relevance
Project Narrative Tissue-resident memory T cells (TRM) have been detected in the Cerebrospinal fluid (CSF) and central nervous system (CNS) of patients with multiple Sclerosis (MS). There is, however, a paucity of information regarding the characteristics and functions of CD4+ tissue-resident memory T cells during CNS autoimmunity. In this proposal, we will use novel tools to characterize CD4+ TRMs during experimental autoimmune encephalomyelitis (EAE) and address their role in disease progression and relapses.